The Institute for Health Equity Research Catalyst Center

PROJECT SUMMARY/ABSTRACT
Health disparities science has advanced significantly over the last two decades, yet complex challenges remain.
Improving the health and health care of populations, and by extension the health of all communities, will require
a robust, transdisciplinary minority health and health disparities (MH/HD) research workforce with expertise in
health equity research methods and approaches, and experience engaging with communities and multi-sector
stakeholders. Emerging MH/HD researchers will need to become adept at designing multi-level, multi-domain
studies to address the many intersecting factors and sources that contribute to health disparities and should be
committed to engaging communities across all phases of research, from the development of research questions
to dissemination of findings to scientific and non-scientific audiences. We propose to establish the Institute for
Health Equity Research Catalyst Center at the Icahn School of Medicine at Mount Sinai, guided by an
Appreciative Inquiry framework. The Center will provide scientific training and funding support to promote the
engagement, advancement, and retention of investigators across Mount Sinai in community-informed research
focused on understanding and eliminating health disparities. A key priority will be bi-directional capacity building
in MH/HD research (investigators  community partners), and we will engage community partners across Center
programs and activities. The Center’s aims are to: (1) Build on existing strengths, expertise, and resources to
develop the Center’s governance, programmatic, and evaluation components (Administrative Core); (2) Catalyze
efforts to conduct MH/HD research to support trainees/faculty at all levels and across all disciplines through
education and training; and implement the Catalyst Scholars Pilot Project Program for early-stage investigators
planning to submit NIH K or R applications (Investigator Development Core (IDC)). Pilot projects will be required
to: focus on disparities populations, incorporate domains from the NIMHD framework, and include community-
engaged approaches; (3) Leverage our existing, expansive academic-community partnerships to convene a
Catalyst Community Board (CCB) to collaborate with the IDC on all aspects of the Center’s work (Community
Engagement and Dissemination Core/CEDC) and link Scholars to community consultants, and research and
dissemination partners. Catalyst activities for all faculty and trainees include Health Equity Research Methods
and Approaches Workshops & Seminars, a health disparities consultation service, multi-sector summits. Catalyst
Scholars will be paired with health equity mentors, have access to experts in MH/HD research approaches and
methods, and participate in research methods workshops, health equity seminars and career development
activities; they will present their work to the CCB for input at project start-up and upon completion to co-develop
novel dissemination strategies. We will evaluate all programs/activities and the Center’s overall performance to
create and share a blueprint for others to build similar centers. Catalyst will become a dynamic transdisciplinary
Center producing MH/HD research designed for rapid translation to policy, practice, and measurable impact.

Public health relevance
PROJECT NARRATIVE The Institute for Health Equity Research Catalyst Center will provide scientific training and support to promote community-informed minority health and health disparities research. Catalyst will focus on health equity science methods and approaches; the development of robust, sustainable academic-community partnerships; and the creation of novel dissemination strategies for scientific and non-scientific communities. Through an innovative pilot project program, Catalyst Equity Scholars will be supported with funding, mentoring, and unique research training, and career development activities in collaboration with a network of community partners, providing opportunities for multi-sector learning and partnership with the goal of rapid translation of research to policy and practice.